Dissecting the Role of Radiation in Regulation of MHC-I and Neoantigen Presentation

Abstract:
Immunotherapy has recently emerged as a promising new approach to cancer treatment. Durable anti-tumor
responses have been achieved with immune checkpoint inhibitors (ICIs) such as anti-PD1 and anti-CTLA4.
However, most cancer patients respond poorly to ICIs, including soft tissue sarcoma patients. An important
research objective in improving therapy for soft tissue sarcoma patients is to understand pathways that are
associated with resistance to ICIs. Downregulation of the antigen presentation pathway has been associated
with resistance to ICIs in various cancers. Radiation therapy, on the other hand, has been shown to increase
antigen presentation. Although it has been postulated that radiotherapy enhances therapeutic effects of ICIs
through upregulation of MHC-I molecules, the regulatory pathway(s) for radiation-induced MHC-I upregulation
remains poorly understood. To investigate the role of radiotherapy in modulating tumor antigen presentation, I
will use genetically engineered mouse models of autochthonous soft tissue sarcomas to dissect the
mechanisms responsible for modulating MHC-I expression after radiation.
The long-term goal of this project is to elucidate the mechanisms by which radiotherapy can help to overcome
immunotherapy resistance. The primary objective of this proposal is to investigate the underlying pathway
through which radiotherapy modulates the MHC-I antigen presentation pathway. The central hypothesis of this
study is that radiotherapy upregulates MHC-I expression in soft tissue sarcomas, which increases neoantigen
presentation to the immune system and sensitizes tumor cells to cytotoxic T cell killings and ICI treatments. I
will test this hypothesis in the following two specific aims:
Aim 1: Investigate regulatory networks responsible for MHC-I expression in soft tissue sarcomas.
Aim 2: Test whether radiation increases neoantigen presentation on tumor cells and antigen-presenting cells in
vivo.

Public health relevance
Project Narrative: Many preclinical studies using transplanted tumor models demonstrate that radiotherapy can synergize with immune checkpoint inhibitors to generate systemic immune responses. However, clinical trials have shown that only a small percentage of patients respond well to dual therapies. This proposal is relevant to public health because it will characterize both the mechanisms through which radiation overcomes resistance to immune checkpoint inhibitors, as well as the immune system's responses to upregulated neoantigen presentation after radiotherapy. Knowledge gained from this project may reveal novel targets for enhancing responses to immunotherapy in both sarcomas and other cancer types, and, thus, contributes to the NCI's mission to alleviate the burden of cancer in patients.